Phosphodiesterase 1 (PDE1) Regulation of Myocardial Calcium and Function

PROJECT SUMMARY
The cyclic nucleotide cAMP serves as a second messenger critical in multiple
cellular processes. Two proteins help to regulate the level of cAMP. G-protein coupled
receptors (GPCRs) are transmembrane proteins involved in cAMP production. G
proteins are heterotrimeric, and a subset of GPCRs consists of a stimulatory, catalytic
G⍺ subunit (G⍺s) that upon receptor ligand binding, increase adenylyl cyclase (AC)
production of cAMP. Phosphodiesterases (PDEs), on the other hand, hydrolyze cAMP
into AMP. In heart failure animal models and human patients, PDE1 inhibition helps to
improve cardiac function by increasing myocardial contractility, improving relaxation,
and vasodilating to lower hemodynamic stress on the heart. These effects are similar to
those upon PDE3 inhibition, but whereas the latter is associated with fatal arrhythmias,
no arrhythmic events have been associated with PDE1 inhibitor use.
Compartmentalized cAMP signaling that is unique to PDE1 vs PDE3 may help to
explain this important difference. It is known that specific PDE-GPCR pairings work
together to regulate distinct pools of cAMP. The heart expresses more than 200 GPCRs
and 3 cAMP-hydrolyzing PDEs (1, 3, and 4). Unique pairings help to establish
compartmentalized gradients of cAMP signaling that enable the modulation of specific
cellular processes in response to different stimuli. While multiple GPCR pairings with
PDE3 or PDE4 have been known, which GPCR(s) pair with PDE1 remains unknown. In
this Diversity Supplemental project, we will identify the GPCR(s) that functionally
enhance(s) the positive inotropic effects of PDE1 inhibition. We will do so by employing
cardiomyocyte contractility and calcium, and forster resonance energy transfer (FRET)
imaging experiments, and cardiac slice physiologic studies. Guinea pig hearts, which
are much more like the human heart in PDE biology versus the commonly used rat and
mouse models will be used. Our hypothesis is that PDE1 will establish a G⍺s-
associated cAMP gradient that is distinct from that regulated by PDE3. This is an
important question because of clinical potentials of PDE1 inhibition in patients with
Parkinson’s Disease or heart failure. The completion of our aim will thus contribute
original findings with direct clinical relevance that can potentially help improve the health
and life quality of patients.

Public health relevance
Project Narrative Heart failure drugs help to improve cardiac performance. These drugs can work in a number of different ways inside the cell, with some ways much better delineated than others. This project will focus on one of the lesser- known ways to help us envision new and more effective ways to treat heart failure.